Intersection of causal neurodevelopmental disorder risk genes, cortical circuit function, and cognitive processing required for behavioral adaptions

PROJECT SUMMARY
Neurodevelopmental disorders (NDDs), like most neuropsychiatric disorders, are defined in general terms
through cognitive impairment and behavioral alterations. Advances in genome sequencing from large patient
populations has led to the identification of genes that cause complex NDDs. As a result, a major area of
basic research related to NDDs is to understand how these high-impact genetic risk factors disrupt molecular
and cellular mechanisms in brain cells and how these cellular alterations translate to changes in circuitry
and behavior. This ongoing R01 has historically focused on the neurobiological impact of a consensus NDD
risk gene, Syngap1, on the assembly and function of cortical synaptic connectivity in mice. In the current
budget period, we have made progress toward understanding the extent of touch-mediated behavioral deficits
and dysfunction within cortical circuitry that processes touch in the Syngap1 mouse model. The upcoming
budget period seeks to understand the cause-and-effect relationships between altered assembly, function,
and plasticity of cortical circuits and touch-associated behavioral maladaptations in this model. Based on
mounting published and unpublished preliminary data, we will test the overarching hypothesis that
Syngap1 regulates cognitive function and behavior by sculpting cortical circuits that promote tactile
perception. This hypothesis is relevant to NDD etiology because altered sensory processing is a ubiquitous
manifestation of NDDs, including ASD, SCZ, and ADHD. An idea gaining momentum in the field is that
alterations to cognitive function and behavior are caused, at least in part, through impaired sensory
processing within cortical circuits. This research topic is relevant to mental health disorders because
cognitive function is a major domain of brain function and perception is a construct that defines it. However,
the circuits that support perception, how they directly impact behaviors relevant to mental health disorders,
and how major genetic risk factors regulate them, remains poorly understood. Aim 1 will determine how
Syngap1 expression within tactile processing cortical neurons contributes to tactile learning and behavioral
phenotypes in Syngap1 mice. Aim 2 studies will determine how Syngap1 regulates mesoscale cortical plasticity
during tactile learning. Aim 3 is designed to provide insight into how Syngap1 expression in forebrain excitatory
neurons contributes to modulation of hindbrain arousal centers that support reinforcement learning. Overall
Impact: The proposed research has the potential to define cortical circuits that causally link impaired
sensory processing directly to NDD-associated cognitive and behavioral impairments. Such studies are
expected to inform the growing idea in the field that impaired cortical sensory processing directly leads to
behavioral maladaptations common to NDDs.

Public health relevance
NARRATIVE Complex neurodevelopmental disorders (NDDs) are characterized by cognitive impairment, maladaptive behaviors, and disrupted sensory processing, though it remains unclear how these distinct manifestations are mechanistically (neurobiologically) related. Using animal models of causal NDD genetic risk, this project will define how cortical circuitry required for sensory processing causes cognitive impairment that leads to maladaptive behaviors.